Rocky Mountain Summer Research Education Experience

Project Summary
The Rocky Mountain Summer Research Education Experience (RMSREE) Program will fill a
critical need to increase the STEM knowledge and understanding of Denver area high school
teachers, enhancing the STEM content in the K-12 educational agencies in which they teach
and ultimately resulting in increased participation and better training of the biomedical sciences
research workforce.
The main goals of the RMSREE program are: 1) to provide substantive research training,
individualized academic preparation, and career guidance to strongly enhance the skills of the
RMSREE teacher participants, Research Education Fellows; 2) to recruit a diverse set of
Fellows who are committed to translating their research experience into enhanced STEM
education in their classrooms and provide them with professional development opportunities to
effectively bridge the gap between the research setting and the HS STEM classroom; and 3) to
continue to create and sustain long-term connections between CU Denver and local high
schools that will improve the STEM education of HS teachers as well as provide a STEM
pipeline for their students to enter into the biomedical imaging, bioengineering, and health
informatics professions. The RMSREE program holds high expectations for performance (95%
of participants adding significant STEM content by the end of their first year and 80%
maintaining that level over the five-year period following the program). To achieve these
ambitious outcomes we will recruit cohorts of highly-committed, ambitious candidates and
engage them in an integrated set of activities, centered around meaningful research
experiences, but also augmented with mentoring through individualized feedback on
professional development plans (PDPs), a weekly seminar series, and training in laboratory
culture and the responsible conduct of research. This will build participants' research skills and
STEM content knowledge and understanding as well as promote their progression to become
more effective STEM teachers. Group activities will contribute to building a cadre of trainees
who will continue to support each other throughout their careers to optimize professional
success. The RMSREE program will serve six Fellows each year, for a total of thirty trainees
over the 5-year project period, which will in turn impact many hundreds of their students in the
years following the project.

Public health relevance
Project Narrative The Rocky Mountain Summer Research Education Experience (RMSREE) Program will provide substantive research training, individualized academic preparation, and career guidance to strongly enhance the skills of the high school teacher participants in the fields of biomedical imaging, bioengineering, and health informatics. The project is designed to aid them in translating their research experience into enhanced STEM education in their classrooms and to provide them with professional development opportunities to effectively bridge the gap between the research setting to the high school STEM classroom.